Single-Molecule Assembly of Protein-DNA Complexes

DESCRIPTION (provided by applicant): The long-term objective of this proposal is to understand the behavior of proteins at the level of solitary protein-DNA complexes. This proposal takes advantage of a novel single-molecule approach that can visualize the behavior and dynamic properties of individual complexes of proteins with DNA. Several different protein-DNA complexes will be examined;each is an essential component of the DNA recombination process. The proteins that will be examined include the DNA strand exchange proteins, RecA and Rad51;the mediators and modulators of RecA/Rad51 function;and the finally the nucleoprotein- and chromatin-remodeling translocase, Rad54 protein. The specific aims are to: 1. Visualize and measure the assembly, disassembly, and polarity of RecA and Rad51 nucleoprotein filaments. This aim addresses the core behavior of the RecA/Rad51 nucleoprotein filament - its dynamic behavior and its ability to find DNA homology. 2. Determine how the dynamic behavior of RecA/Rad51 nucleoprotein filaments is modified by competitors and mediators. This aim addresses the question of how competitor, mediator, and motor proteins modulate the behavior of RecA and Rad51 filaments. 3. Define the role of translocation along dsDNA by Rad54 protein. This aim addresses the functions of Rad54 translocation capacity and its ability to remodel protein-DNA complexes. The visualization of these proteins acting at the single-molecule level, in real-time, affords a completely new window into the behavior and function of these proteins. Each of these proteins is involved in the repair of DNA breaks by recombination, a process whose mechanism is not fully understood. Recently, new methods of visualizing the action of these repair enzymes on single-molecules of DNA have been developed. These methods can provide an unprecedented level of understanding of these intricate processes. These single-molecule methods will be used to define some of the molecular events comprising increasingly complicated biochemical processes that underpin recombinational DNA repair. PUBLIC HEALTH RELEVANCE: Project Narrative Genetic recombination is a fundamental biological process that is necessary for the maintenance of chromosomal integrity. The research in this proposal is significant because it provides basic information about the protein-protein and protein-DNA interactions that are essential for normal DNA-break repair by recombination. A major function of recombinational DNA-break repair is the prevention of genomic rearrangement. These proteins are responsible for preserving genetic integrity in all organisms and, when defective in humans, are responsible for a variety of diseases. Left unrepaired, these DNA breaks can result in genomic instabilities that that might permit tumorigenesis. Mutations in the human counterparts of these proteins result not only in predispositions to cancer, but give rise to aberrant meiosis and embryonic lethality. Understanding the molecular mechanism of this process should shed light abnormal biological events that lead to chromosomal translocations and genome instability. Consequently, a detailed molecular understanding of recombinational DNA repair is important to human health.